Family caregivers in later life: A longitudinal study of well-being and mental health in families of adults with autism and developmental disabilities

Project Summary/Abstract
This project aims to improve our ability to support the resilience of family caregivers of adults with autism and
developmental disorders as the caregivers move into later life. Based on a 30 year longitudinal study that
prospectively followed families from when their children were referred for possible autism or developmental
delays, we will use a social convoy model to investigate trajectories of social connectedness and isolation over
the next five years as they affect caregivers’ mental health and well-being. This model describes changes in
social connectedness over time that may increase vulnerability or reduce the effects of caregiver burden. We
examine additional interacting factors specifically related to family caregiver well-being and mental health in
families with adult children with developmental disabilities. We will use questionnaires, app-based diaries, face
to face interviews and exploratory measures of biological and cognitive aging over the course of 5 years during
which our sample is in their 60’s, linked to rich behavioral data from the past 20-30 years. Our objective is to
identify life milestones, such as retirement and the adult child’s moving out, as well as caregiver coping
strategies that allow us to support well-being and mental health in family caregivers as they age.

Public health relevance
Project Narrative This prospective study will examine the factors that account for variability in the trajectories of well-being and mental health in family caregivers of young adults with autism and other developmental disorders, linking them to biological measures of accelerated aging. Social connectedness, generative activities, cumulative caregiving burden, life events and transitions, family functioning and demographics and young adult characteristics will be evaluated as potential contributors to positive and negative outcomes in family caregivers. This study will inform our understanding of the types of supports needed for caregivers of aging individuals with autism and other developmental disorders.